THYROTROPIN RELEASING HORMONE AND PREVENTION OF CHRONIC LUNG DISEASE

To test the response to TRH among infants treated antenatally with corticosteroids and postnatally with surfactant to evaluate both benefit and possible adverse effects.